Healthspan Core

Core B: Project Summary:
The objective of Core B (Mouse Aging Analysis Core ) is to provide a centralized core facility for the PPG at
the Yale School of Medicine that will generate and analyze transgenic mouse models to determine the roles of
local adipose FGF21 on lifespan extension and age-related functional decline across multiple systems. The
Core B will allow the PPG to gain mechanistic insights into the pro-longevity effects of local FGF21 and role of
augmentor-α-ALK signaling, across multiple organ systems (adipose tissue, liver, bone, CNS and the immune
system) using measures of functional decline in aging, longevity and burden of disease as primary endpoints.
The Aim 1 of Core B is be work closely with the leader of the Administrative Core and leaders of the research
projects, to assist in the experimental design and execution of the animal research phase of the individual
projects, and to assure efficiency and standardization of procedures. Aim 2: To complete the omnibus study
with male and female mice examining the effect of adipose specific inducible overexpression of FGF21 on
lifespan. Aim 3: To determine the impact of FGF-21 superagonist (FGF21SA) on lifespan, inflammaging and
healthspan. Aim 4: To perform healthspan analyses of mice with overexpression of FGF21 mouse in
augmentor-α knockout models.

Public health relevance
Core B: Project Narrative: The analysis of lifespan and healthspan in mice require specialized and centralized facility to conduct metabolic testing, behavior tests like age-related changes in memory and cognition. The mice where local FGF21 levels are elevated are predicted to live long. This Core will conduct detailed analyses of disease burden and pathology to determine the cause of lifespan extension and to understand the aging process.